LONG TERM FOLLOW-UP CLINIC FOR SURVIVORS OF CHILDHOOD CANCER AND PEDIATRIC HEMAT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to evaluate the impact of a program of comprehensive, long-term, follow-up care for childhood cancer and pediatric HSCT survivors. This program will be evaluated for its ability to identify complications of childhood cancer therapy and pediatric HSCT, to develop treatments or preventive measures for these complications, and to develop interventions aimed at improving the quality of life in childhood cancer and pediatric HSCT survivors.